Enhancing Connections-Palliative Care: A Cancer Parenting Program for Patients with Advanced Cancer and Their Children

PROJECT SUMMARY/ABSTRACT
The purpose of the proposed study is to test the short-term efficacy of a cancer parenting education
program for child-rearing parents diagnosed with non-curable cancer, called Enhancing Connections-Palliative
Care Program (EC-PC). The program consists of fully scripted intervention sessions that will be delivered by
telephone by a specially trained patient educator. The EC-PC has been pilot tested and is ready for efficacy
testing. Parents will be eligible if they are diagnosed with non-curable cancer [determined by TNM Stage IV
cancer for hard tumors or 2 or more cycles of treatment failure with disease relapse in non-solid tumors]; read,
write and speak English as one of their languages of choice; have a child between the ages of 5-17 living in the
home at least 50% of the time with the ill parent and another non-ill parent or parent surrogate; and have access to a
telephone. Study participants will be recruited from 4 study centers: University of Washington/ Seattle Cancer
Care Alliance; Georgetown University/ Lombardi Comprehensive Cancer Center; University of Hawaii/ Hawai’i
Cancer Center, and Southeast Oncology/University of South Carolina. After completing signed informed
consent and baseline measures, parents will be randomized to an experimental or alternative treatment control
group. The experimental group will receive 5 telephone-delivered educational sessions every 2 weeks by
specially trained patient educators. The control group will be mailed “What Should I Say to the Children?”, a
guide for parents with advanced cancer, and be phone contacted by a specially trained patient educator who
will use a script to guide the parent on ways to gain the most information from the booklet. Primary endpoints
for testing efficacy will be assessed at 3-months post-baseline using Linear Mixed Models using an intent to
treat analysis and a per-protocol analysis. Five primary outcomes will assess efficacy: parents' anxiety and
depressed mood; parents' skills in helping their child manage the toll of the parents' cancer; parents' self-
efficacy in talking with their child about the child's cancer-related concerns; and the child's anxious/depressed
mood. The stability of changes will be described and evaluated at 6- and 9-months. With estimated Effect sizes
of .33-81 on the primary outcomes, the study will have greater than 0.80 power to detect a significant
difference between the experimental and control group, p=.05 (2-tailed).
Our sample for analysis will be 492 diagnosed parents and their 492 non-ill coinhabiting partners/parent
surrogates of children ages 5-17. In addition to testing efficacy, the proposed study will test the theoretical
model of the intervention using structural equation modeling with confirmatory factor analysis; evaluate the
impact of the intervention on children’s behavioral-emotional adjustment whose parents die during the study
using Linear Mixed Models on data obtained from the non-ill parent; and examine the moderating effects of
parents' symptom burden and family environment on treatment outcomes using Linear Mixed Models.

Public health relevance
PROJECT NARRATIVE The proposed study is responsive to the mission of the research priorities of the National Institute of Nursing Research and the National Cancer Institute: to reduce health disparities for racially, ethnically, and financially disadvantaged persons, including promoting and improving the quality of life of individuals and families. It is directly related to evidence-based palliative care to enhance psycho-behavioral adjustment to trauma-exposed parents and children impacted by a parent's life-threatening illness.